Translational Imaging and Behavioral Assessment (TIBA)

ABSTRACT
Translational Imaging & Behavioral Assessment (TIBA) Core
Cognitive Neuroscience of Development and Aging (CoNDA) Center
Critical to understanding the basis of neurocognition and behavior is the imaging of brain structure and function,
and ultimately linking these measures to behavioral and cognitive phenotypes. The Translational Imaging and
Behavioral Assessment (TIBA) Core of the Cognitive Neuroscience of Development and Aging (CoNDA) Center
in Phase II will support Research Project Leaders (RPLs) and Pilot Project Investigators (PPLs) who are
performing research in animal models of neurocognitive disorders. The TIBA Core will also be available to other
investigators across the CoNDA Campus. The TIBA Core will provide shared centralized research resources
that provide access to technologies, instruments, as well as expert consultation and other services to scientific
preclinical investigators. The core is composed of three sub-cores to support imaging and behavioral
experiments. The Small Animal Magnetic Resonance Imaging (SAMRI) sub-core provides structural and
functional imaging on a broader scale. The Intravital Imaging sub-core provides access to a multiphoton
microscope and a fluorescent light sheet microscope for functional and structural, cellular and circuit analysis of
animal brains. Finally, the Animal Behavior sub-core provides a broad panel of behavioral and cognitive
assessments in translational models for neurodevelopmental and neurodegenerative disorders. The TIBA Core
was established during the second year of Phase I and has grown tremendously in types of services provided
and number of users and grants it supported. The TIBA Core will be directed by Dr. Dunaevsky (overall TIBA),
with sub-cores directed by Dr. Liu (SAMRI), Dr. Jensen-Smith (Intravital Imaging), and Dr. Samuelson (Animal
Behavior).